Mechanisms of meiotic and mitotic recombination

ABSTRACT
Recombination is both a means to avoid genome instability and to process that generates genome instability.
In meiosis, DNA double-strand breaks are repaired into crossovers that are essential for accurate
segregation of homologous chromosomes; defects in this process result in sterility or aneuploidy, the major
cause of pregnancy loss and trisomy. Conversely, in mitotically proliferating cells double-strand breaks are a
dangerous class of DNA damage. Repair of breaks in this context is done without making crossovers;
formation of crossovers in mitotic cells can lead to chromosome rearrangements and tumorigenesis.
Research in my laboratory focuses on mechanisms that promote crossovers in meiotic cells and non-
crossover outcomes of repair in mitotic cells. We have made important contributions to understand these
problems for 20 years, during which time I have trained numerous scientists who are active in research and
research-related careers. This proposal sketches out both continued and new directions that will drive the
field forward. These include investigations of how large gaps are repaired (important for designing Cas9
fragment integration experiments and Cas9-based gene drive systems) and how meiotic crossovers are
patterned (important for proper segregation of chromosomes into gametes). We use a combination of
genetics, primarily using Drosophila as a model organism, genomics, biochemistry, cell biology, evolutionary
biology, and mathematical modeling.

Public health relevance
NARRATIVE Genetic exchange between homologous chromosomes is essential to ensure that they segregate accurately in meiosis, the specialized cell division that gives rise to eggs and sperm. Errors in recombination can lead to an incorrect number of chromosomes, which is the most common cause of birth defects and miscarriage. However, the same type of exchange in other cells can lead to cancer. This proposal seeks to understand how exchange is promoted in cells undergoing meiosis but avoided in other tissues, in terms of both regulation and molecular mechanisms of recombination processes.